Unraveling dentin and enamel roles on the development and progression of wedge-shaped noncarious cervical lesions

PROJECT SUMMARY/ABSTRACT
Noncarious cervical lesions (NCCLs) are a common dental condition that can result in significant loss of tooth
structure and pain, affecting the individual throughout their lifetime. Available intervention options for this
condition are limited and not effective long-term. This condition has high prevalence among adults (up to 85%
in specific populations), however there is scarce information concerning mechanisms leading to the condition
and its progression, especially for wedge-shaped NCCLs. The on-set of these lesions, which can affect
different teeth in the individual cannot be explained based on current evidence. There is a significant gap in the
understanding of mechanisms behind dentin breakdown during the establishment of wedge-shaped lesions,
which may be linked to changes in the dentin organic matrix composition and morphology. Our preliminary
data has shown compositional differences of NCCL-affected teeth when compared to sound teeth, indicating
that there is a critical need to evaluate the specific roles that enamel and dentin may play in the development
and progression of this prevalent condition. The goal of this R03 is to investigate the individual relative
contributions leading to tooth breakdown, characterized by loss of mineral and organic components, largely
affecting dentin within the cementoenamel junction. To achieve this goal we will investigate compositional,
morphological, and histological changes in the affected dentin and enamel (aim 1); and the relationships
between those and the biomechanical properties of NCCL-affected dental tissues that could impair the
protective mechanisms of the tooth. Dentin and enamel biomechanical properties will be characterized at the
nanoscale and relationships will be investigated between key components of the dentin extracellular matrix,
including biodegradative mechanisms and the nanomechanical properties of the wedge-shaped NCCL-affected
(bounding) tissue (aim 2). Our approach is innovative considering previously unknown factors related to this
prevalent condition and providing data for future comprehensive funding mechanisms. Furthermore, these
findings will be the key to our long-term translational goal, which is the establishment of targeted successful
therapeutic approaches for the prevention and decrease in prevalence of this condition.

Public health relevance
PROJECT NARRATIVE Wedge-shaped noncarious cervical lesions can occur in one or more teeth within the same individual's dentition. This condition remains poorly understood, with scientific gaps concerning the roles that dental mineralized tissues play in the establishment and progression of these lesions. Building on this knowledge, our long-term goal is to develop early diagnostic, preventive, and reparative approaches aimed at reinforcing compromised dental structures and halting lesion progression.